Determinants of differentiation and maintenance of PD-1+ CD8 T cells

SUMMARY
Recent findings identified that Programmed Cell Death (PD)-1+ CD8 T cells recognizing tumor or chronic
pathogens have a division of labor: T cell factor (TCF)-1+ PD-1+ CD8 T cells function as memory-like resource
cells and TCF-1neg PD-1+ CD8 T cells have effector-like function. TCF-1+ PD-1+ CD8 T cells self-renew and
differentiate into effector-like and terminally differentiated/more exhausted TCF-1neg PD-1+ CD8 T cells. TCF-1+
memory-like cells have high expression CD28, and we have shown that during PD-1 targeted therapies CD28
costimulation is required for the reinvigoration of CD8 T cell responses. In addition, memory-like cells have high
expression of ICOS, and a gene expression program with similarities to follicular helper CD4 T cells. Our
preliminary data suggest that during established chronic lymphocytic choriomeningitis virus (LCMV) infection,
continuous CD28 signaling is required for differentiation and self-renewal of TCF-1+ memory-like PD-1+ CD8 T
cells. In contrast, ICOS signaling diminishes differentiation into effector-like cells. How memory-like cells choose
between self-renewal and differentiation, and how to modulate differentiation into effector-like cells are critical
questions. In addition to a unique set of costimulatory molecules, TCF-1+ memory-like cells also express a
distinct set of chemokine/cytokine receptors. Based on these data and the knowledge gap in the field, we propose
to define the role of costimulation in the maintenance and differentiation of PD-1+ CD8 T cells (Aim 1) and
uncover the impact of cellular interactions (Aim 2). In Aim 1, we will determine how CD28 and ICOS
costimulation affect TCF-1+ memory-like PD-1+ CD8 T cells and identify transcriptional regulators of T cell fate.
In Aim 2, we will use an unbiased approach to identify cellular interactions of TCF-1+ memory-like PD-1+ CD8 T
cells in vivo and probe the biological consequences of these interactions for T cell fate decisions. XCL-1, a
chemoattractant for XCR1+ dendritic cells (DC1) is highly expressed by TCF-1+ memory-like cells and modulated
by CD28 signaling. We will address the role of DC1 antigen presentation and XCL-1 production on localization,
differentiation and self-renewal of TCF-1+ memory-like PD-1+ CD8 T cells. Understanding the determinants of
self-renewal and differentiation of T cells chronically exposed to antigens would have broad implications for
immunotherapies in many pathologies (chronic infections, cancer, autoimmunity, transplantation and allergy).

Public health relevance
NARRATIVE Even though T cells are exposed to persistent antigen in chronic infections, cancer, autoimmunity and transplantation, we know very little about how T cell responses are maintained or how their function is modulated during chronic antigen stimulation. In this proposal, using a mouse model of chronic viral infection, we will study how co-stimulation and cellular interactions shape the maintenance and function of PD-1+ CD8 T cell responses. This understanding will be critical to understand fate decisions by chronically stimulated CD8 T cells and to improve immune interventions.